BIOSYNTHETIC HGH IN PROMOTING LINEAR GROWTH IN GROWTH DEFICIENT CHILDREN

This study is evaluating the ability of Eli Lilly biosynthetic human growth hormone to produce growth when given to growth hormone deficient children in a dose of 0.06 mg/Kg, i.m. three per week.